Molecubes PET/CT system

ABSTRACT
This proposal requests funds to acquire a new state-of-the-art MOLECUBES small animal imaging system with
Positron Emission Tomography (PET) and Computed Tomography (CT) capabilities to support pre-clinical
research at the University of Texas Southwestern Medical Center (UTSW). This multi-modality system includes
the highest sensitivity PET system commercially available and a high-resolution CT for routine animal imaging
with low radiation exposure. This equipment is selected compared to other commercially available scanners,
also because of its compact size and light weight, user-friendly interface and intuitive workflow, high-
throughput imaging capability, modular design enabling future expandability, as well as compatibility with other
existing devices. UTSW has a long and successful record of accomplishment in conducting ground-breaking
biomedical research. Many projects significantly benefit from in vivo imaging to acquire structural and
functional information. Especially with the establishment of Cyclotron and Radiochemistry Program offering
onsite production of novel PET tracers, a UTSW program funded by the Cancer Prevention and Research
Institute of Texas (CPRIT), desire for pre-clinical PET/CT imaging has been growing substantially because of
more scanning opportunities, access to short-lived isotopes, more types of isotopes for expanded research
endeavors, and reduced costs associated with isotope transport from elsewhere. Nonetheless, currently there
is only one PET/CT scanner in UTSW, which employed older-generation PET/CT technologies and cannot
meet the technical needs in imaging quality and scanning efficiency. More critically, this scanner is located
outside the Specific-pathogen-free animal facility, substantially limiting scope of projects behind the animal
barrier, e.g. those using immuno-deficient animals, and prohibiting studies requiring multiple PET/CT scans,
e.g. for longitudinally monitoring disease progression. The requested PET/CT will be installed in and managed
by PreClinical Radition Core Facility (PCRCF) of UTSW located behind the animal barrier, a CPRIT-funded
shared resource facility for in vivo imaging and radiation technologies and services. This setting allows
maximally taking advantages of existing instrument and management infrastructure of the PCRCF to provide
users a one-stop solution to access all major imaging modalities (PET/CT/MR/Optical imaging) and radiation
delivery techniques (image-guided small animal irradiator), as well as extensive imaging and radiation physics
expertise. To demonstrate the need for the requested PET/CT, we have assembled Major and Minor user
groups. Their diverse spectrum of projects, majority of which funded by the NIH, ensures adequate use of the
equipment. We have formed an Advisory Board to oversee the PET/CT operation and developed a sustainable
financial plan. The requested instrument will meet a significant need of our institution for state-of-the-art in vivo
imaging behind the animal barrier. It will improve accuracy and efficiency of projects it supports, as well as
open new opportunities for our investigators.

Public health relevance
NARRATIVE We request funds to acquire a state-of-the-art preclinical PET/CT scanner. PET enables the visualization and quantification of biological processes using radiotracers and CT offers high-resolution anatomy images. This instrument will meet a significant need of our institution for non-invasive in vivo imaging behind the animal barrier, which will contribute to the enhancement of ongoing and future research.